Cannabis use and its association with daily functioning in young adults with chronic pain: an ecological momentary assessment burst design

PROJECT SUMMARY/ABSTRACT
Cannabis use among young adults has increased dramatically over the past decade, with nearly 1 in
3 young adults in the U.S. reporting past month use. Young adulthood is a high-risk period for the
development of substance use problems in general and a subset of young people may be at especial
risk: those with chronic pain. Chronic pain is a major public health concern associated with significant
morbidity and mortality. Although underrepresented in pain research, epidemiological surveys and
systematic reviews suggest that up to 20% of young adults experience recurrent or persistent pain
problems that are associated with a wide range of negative outcomes, including poor sleep, physical
activity limitations and reduced quality of life. Due to widespread beliefs about its pain-relieving
properties, young adults with chronic pain may be using cannabis to manage their symptoms.
Although cannabis has garnered considerable attention as a potential treatment for chronic pain, its
therapeutic potential—especially in young adults—remains unknown. Further, the impact of
naturalistic cannabis consumption on functional outcomes, including pain-related impairment,
physical (in)activity, and sleep is poorly understood. The overall objective of the proposed study is to
holistically examine how cannabis use is related to pain and functioning (i.e., pain-related disability,
physical (in)activity, sleep) in the daily lives of young adults with chronic pain. The proposed research
will use an innovative 6-month longitudinal measurement burst design to capture momentary
experiences and changes over time in a projected sample of N = 60 cannabis-using young adults with
chronic pain. We will examine relationships between naturalistic cannabis use, pain perception and
functioning in participants’ daily lives during three 2-week ecological momentary assessment (EMA)
periods each separated by approximately 8 weeks. This approach will enable the research team to
track intraindividual change including nuanced daily associations and longer-term change with less
burden to participants. We will test how daily pain and functioning vary as a function of cannabis use
at the momentary and daily level and whether these relationships (as well as cannabis use patterns)
change over time. The results of this study will allow us to determine the conditions under which
cannabis may improve or impair daily functioning and well-being among young adults with chronic
pain. These findings will directly inform the development of a larger study to identify adaptive and
maladaptive cannabis use patterns of young adults and the longer-term impact of cannabis use on
pain and pain-related functioning. Our ultimate goal is to identify and test novel targets or critical time
points for effective chronic pain and substance misuse prevention, both of which represent national
research priorities.

Public health relevance
PROJECT NARRATIVE Young adults with chronic pain are a vulnerable and underrepresented pain population; despite many young adults using cannabis products for pain relief, little is understood about the effectiveness of cannabis to manage chronic pain while balancing other potential risks (e.g., cannabis dependence, decreased physical activity). The proposed research will capture momentary experiences and changes over time to establish a more holistic understanding of how cannabis use is related to pain and functioning in daily life. These findings will directly inform the development of a larger study to identify adaptive and maladaptive cannabis use patterns of young adults experiencing chronic pain and identify and test novel targets and/or critical time points for effective chronic pain and substance use prevention, both of which are national research priorities.